NEWBORN SCREENING PILOT STUDIES FOR MUCOPOLYSACCHARIDOSIS TYPE II

The purpose of this task order is to support the development, implementation, and provision of proof of concept for identification of newborns with MPS II in the newborn screening setting.